Remotely supervised transcranial direct current stimulation for slowing disease progression in amyotrophic lateral sclerosis (ALS)

PROJECT SUMMARY
ALS affects as many as 30,000 individuals in the United States, with 5,600 new cases diagnosed each year.
Riluzole and edaravone, the only drugs approved by the U.S. FDA for ALS, slow ALS progression; however,
they do not demonstrate marked improvement in ALS symptoms and increase survival time only by a few
months. Hence, most of the care is centered on patient support and symptom management, making
rehabilitation an integral aspect for slowing disease progression, prolonging life span and increasing quality of
life. Our long-term goal is to develop neuromodulation therapies for easy clinical management of ALS.
Transcranial direct current stimulation (tDCS) has been increasingly explored as a promising neuromodulatory
tool to prime motor function in several neurological disorders. Despite the emerging importance of cortical
dysfunction as a pathophysiological biomarker in disease progression, the study of tDCS in ALS is limited.
Here we propose a novel mechanism using remotely supervised tDCS (RS-tDCS) to target hypoexcitable
neural pathways to preserve motor function in individuals with ALS. Due to its low risk, ease of use, and
portability, tDCS is a candidate neuromodality to be administered in a home-based environment with remote
supervision from qualified personnel. Remote supervision would ensure that the stimulation is delivered
optimally in the comfort of a patient’s home, reducing burden on patients and caregivers to travel to the clinic or
research facility and encourage protocol adherence. We aim to investigate the effectiveness and feasibility of
long-term RS-tDCS in individuals with ALS. In a delayed-start design, 38 participants with ALS will be
randomized into remotely supervised tDCS or delayed-start control group. The intervention group will receive
24 weeks of anodal tDCS (3 times/week; 72 sessions). The delayed-start group will first receive sham tDCS for
12 weeks followed by a switch to anodal tDCS for 12 weeks. Aim 1 will investigate the safety and feasibility of
long-term treatment with anodal RS-tDCS in ALS. Aim 2 will determine the effects of 24-weeks of RS-tDCS on
disease progression in individuals with ALS, using the ALS Functional Rating Scale (ALSFRS-R) and other
clinical outcomes. As a secondary aim, we will explore the effectiveness of RS-tDCS on upper and lower motor
neuron mechanisms in individuals with ALS, quantified using transcranial magnetic stimulation and peripheral
nerve stimulation. Successful completion of this project will trigger future studies that will test the clinical
translation of tDCS as a home-based neuromodulatory adjuvant to slow disease progression in ALS and create
a paradigm shift in the clinical management of ALS.

Public health relevance
Project Narrative Amyotrophic lateral sclerosis (ALS) is a progressive and fatal neurodegenerative disorder that affects function of nerves and muscles involved in movement. We propose to study the feasibility and effectiveness of a novel non-invasive brain stimulation paradigm, that can be administered at home with remote supervision, to slow progression of disease and preserve motor function in individuals with ALS. Upon success, this brain stimulation therapy can be easily implemented to improve clinical treatment of individuals with ALS.